MARC at the University of California, Irvine

Project Summary/Abstract
The MARC program at the University of California, Irvine UCI) is a critical component of the School of
Biological Sciences Minority Science Programs (MSP) to increase the number and academic excellence
of underrepresented undergraduates pursuing Ph.D. degrees and careers in biomedical research. The
MARC program has had a transformative institutional impact by preparing an unprecedented number of
underrepresented undergraduates that have obtained research doctorate degrees in biomedical sciences.
MARC activities are designed to introduce participants to biomedical research, improve the academic
preparedness and interest of participants in biomedical research. MARC scholars are introduced to the
excitement of generating new biomedical knowledge in a nurturing environment that stimulates their
critical thinking skills, self-confidence and increases students’ self-identity as scientists. Independent
research conducted under the direction of faculty mentors at UCI and at partner extramural sites serve as
a core element to induce MARC scholars to pursue graduate school and research-focused careers. Over
70 faculty with experience training underrepresented undergraduates and with funded research programs
serve as preceptors of MARC scholars. The MARC research training elements are integrated with the
undergraduate curriculum and include, 1) individual career and academic advising, 2) a research faculty
seminar series, 3) a journal club to introduce scholars to critical reading of current biomedical literature, 4)
training in genomics, computational biology, statistics and methods to enhance reproducibility, 5) training
in responsible conduct of research, 6) independent research directed by faculty mentors, 7) preparation to
present oral presentations and posters at local and national conferences, 8) training in scientific
communications, 9) workshops on application to graduate school, and 10) individual advice during the
graduate school application process.

Public health relevance
Project Narrative The research training and academic preparation of underrepresented undergraduates is critical to ensure that a diverse and highly trained workforce is available to assume leadership roles in the Nation’s biomedical research enterprise, to address the need of improving the health of the people of the United States. This project provides extraordinary opportunities for undergraduates from underrepresented groups to be trained as the next generation of leaders in biomedical research.